Oxytocin-mediated modulation of peripheral mechanical sensibility after injury

SUMMARY.
The current proposal addresses fundamental neurophysiological questions related to oxytocin (OXT)
pharmacology and pain neurobiology in normal and nerve injury settings. We aim to define (a) the OXT PK/PD
relationships on fast-conducting afferents (A-fibers), both tactile (LTMRs: low threshold mechanoreceptors) and
nociceptive (AHTMRs: A-fiber high threshold mechanoreceptors), (b) to study the effects of L5 SNL at the peak
of maximal sensitization (week 2) on injured (L5) and uninjured (L4) afferents and the OXT-mediated modulation
of these sensitization process and (c) to correlate the OXT-induced modulation of sensibility (L4) and excitability
(L5) with the animal behavior (normal or abnormal) after recovery (weeks 8-12).
Our working hypothesis has two parts: 1) that A-fibers response to injury (LTMR: desensitization and AHTMR:
sensitization) is critical for the development of a peripheral mediated neuropathic state and 2) that OXT can
resolve this state and modulate the recovery by rescuing these afferents from they abnormal excitability. We
anticipate that this research will contribute to understanding the physiological effects of OXT, how much of overall
central effects can be explained by the OXT peripheral modulation (interaction with Project 2, Dr. Martin), and
how these effects can be optimized for the treatment of pain in human patients (interaction with Project 3, Dr.
Eisenach).

Public health relevance
NARRATIVE This project will examine the pharmacology and neurobiology of systemically administered OXT in the setting of nerve injury. We have shown that acute and chronic injury produce opposite effects on sensibility and responsiveness of tactile (desensitization) and nociceptive (sensitization) mechano-sensory afferents and the abnormal response of these afferents are critical to the maintenance of the neuropathic state and its recovery after nerve injury. Our published and preliminary data suggest that oxytocin (OXT) may speed recovery from pain after injury by returning peripheral input to normal. These data suggest that OXT may be used as a disease- modifying treatment after traumatic injury. With a base on the strength of our preliminary results, we anticipate that this research will contribute to understanding the role of OXT in the modulation of both normal and abnormal peripheral inputs, how this modulation may affect the recovery after nerve damage (L5 SNL), driving central circuitry, nocifensive behavior and attention (Project 2). We also expect to provide information on these afferents physiological properties and OXT mediated modulation to guide a detailed translational study to be implemented in human patients (Project 3).